Expression Of Heat Shock Genes In Mouse Spermatogenic Cells

We have identified the minimal upstream regulatory region of the Hspa2 gene required to determine the germ cell-type and stage-specific expression of the gene. Different Hspa2 gene promoter fragments were ligated to the Lacz reporter gene and beta-galactosidase expression determined in the testes of transgenic mice. It was found that sequences within 604 bp of the translation start site are required for correct expression. This region was examined further with in vitro methods. Footprint analysis identified two domains protected from DNase digestion by germ cell nuclear proteins, referred to as box 1 (between bp -555 and -503) and box 2 (between bp -346 and -335). These domains contain clusters of transcription factor binding motifs. Gel shift and super-shift analyses indicated that several known transcription factors and at least one novel protein present in germ cell nuclei bind to specific sequences in these regions. An antibody was generated against the unknown protein and ChIP assays have confirmed its association with the promoter and mapped its binding site. The promoter region identified in these studies was used to generate a transgenic mouse that expresses the cre recombinase in pachytene spermatocytes that can be used to produce a conditional gene mutation during meiosis in spermatogenic cells. The HSPA2 protein is synthesized during the meiotic phase of male germ cell development and we hypothesized that it is a chaperone for proteins involved in meiosis. This was confirmed using the gene knockout approach. Disruption of the Hspa2 gene resulted in developmental arrest and apoptosis of pachytene spermatocytes at the G2/M-phase transition of meiosis I. We subsequently found that HSPA2 serves as a chaperone for CDC2 and is required for assembly of the CDC2/cyclin B1 meiosis promoting complex. More recent studies identified an unexpected role for HSPA2, a tight association with the major spermatid DNA-packaging proteins, transition proteins 1 and 2. This suggests that HSPA2 also serves as a chaperone for the transition proteins and participates in the process of nuclear condensation that occurs in spermtids. The HSPA1L protein is present only in spermatids, during the post-meiotic phase of male germ cell development. By analogy with HSPA2, we hypothesized that HSP1L is a chaperone for unique proteins involved in post-meiotic germ cell development or sperm function. Male Hsp1l knockout mice have normal fertility and there are no apparent changes in testis morphology or in sperm numbers. Efforts to replicate earlier evidence that sperm from Hspa1l-/- mice incubated for longer than 30 minutes in vitro became immotile were unsuccessful. Backcrossing studies to determine if the phenotype observed earlier was due to mixed genetic background did not support this conclusion. The lack of an identifiable phenotype in the absence of HSPA1L protein may be due to the high level of HSPA2 protein in spermatids serving a redundant role.